Characterizing the link between multiple environmental exposures and Parkinsons disease exacerbation

Project Summary/Abstract
Parkinson's disease (PD) is one of the fastest growing neurological disorders in the US. The number of people
with PD is projected to increase to over 12 million by 2030, with an economic burden surpassing $79 billion by
2037. The progression of pathogenesis is paralleled by an exacerbation in symptom severity, which underlies
the need for hospitalization. If environmental exposures exacerbate PD symptoms, then days (acute effects) or
years (chronic effects) of higher exposure should result in higher rates of hospitalizations. There is evidence that:
1) air pollution might negatively impact the central nervous system via oxidative stress and neuroinflammation;
2) temperature might increase the risk of PD due to thermoregulatory disorders or medication use; and 3) access
to green spaces might protect against PD exacerbation. While few studies have examined the association
between air pollution, temperature, and greenness and PD, the specific PM2.5 components contributing to PD
are unknown, the effects of weather parameters on PD are poorly understood, and there is a lack of evidence
on how to identify individuals who are at highest risk for adverse PD outcomes. To date, no study has estimated
the link between simultaneous exposure to air pollution, weather, and greenness and PD exacerbation in a
nationally representative population using rigorous statistical methods for confounding adjustment. Our goal is
to conduct national studies to identify the multiple modifiable environmental factors that contribute to PD
exacerbation and increased PD vulnerability. Specifically, in Aim 1 we will conduct national studies to estimate
the chronic effects of 1a) PM2.5, NO2, ozone, PM2.5 components, 1b) greenness, 1c) simultaneous multiple
exposures and their interactions on: a) incidence of first PD hospitalization and b) re-hospitalizations, as
surrogate for accelerated disease severity. In Aim 2 we will estimate the acute effects of 2a) PM2.5, NO2, ozone,
2b) greenness, 2c) mean daily temperature and heat index, 3c) simultaneous multiple exposures on PD
hospitalizations. In both Aims 1 and 2 in main analysis we will use Medicare Part A (inpatient hospitalizations)
for the full study period (2000-2020), and we will then conduct sensitivity analyses using Part A linked to B
(outpatient) and D (medication use) claims to increase rigor in identifying PD cases. In Aim 3 we will develop
and apply machine learning methods and existing methods to identify subpopulations at increased risk. In Aim
4, to ensure transparency and reproducibility, we will develop peer-reviewed, open-source, and computationally
efficient software so other investigators may implement our methods. In summary, findings of this study will
provide evidence on the link between simultaneous environmental exposures and PD exacerbation with the
highest possible scientific rigor, and will identify multiple modifiable risk and protective factors that lead to
increased vulnerability in PD. Completion of this project will provide the foundation to inform actionable policy
(e.g., ensure stringent air pollution standards for PM2.5, implement heat prevention strategies, inform urban
planning) to help slow the PD disease burden and improve the quality of life for millions of Americans.

Public health relevance
This project will leverage data on Medicare enrollees Parts A, B, and D, air pollution (PM2.5, NO2, and ozone), PM2.5 major components, weather variables, greenness, and multiple ZIP code level Census factors to estimate the link between individual and simultaneous exposure to air pollution, PM2.5 major components, weather and greenness and Parkinson’s Disease (PD) exacerbation of symptoms. We will develop and apply new and existing methods to characterize a complex set of possible effect modifiers and identify multiple risk and protective factors that determine vulnerability in PD, and develop open-source R packages, promoting full transparency and reproducibility of findings across different study populations. This project will provide the foundation to inform actionable policy to help slow the PD disease burden and improve the quality of life for millions of Americans.